AMPLIGEN IN PATIENTS WITH CHRONIC FATIGUE SYNDROME AND ASSOCIATED ENCEPHALOPATHY

Patients with severe Chronic Fatigue Syndrome and cerebral dysfunction will receive Ampligen or inactive substance intravenously twice weekly in a prospective, randomized, double-blind study lasting a maximum of 12 months.